SEER TRAINING WEBSITE TECHNICAL SUPPORT, NEW DATA ITEM FEASIBILITY, AND WORKSHOPS FOR ADVANCED TOPICS FOR CANCER REGISTRARS

The purposes of this contract are to provide support to the NCI for: (1) the update and enhancement of the SEER Training Website (STW), in specific in the Cancer Registration and Surveillance modules, and site-specific modules; and obtaining feedback from cancer registrars (CTRs) regarding the modified STW content via virtual focus groups (2) feasibility testing of proposed new data items, and; (3) the 2020 SEER Advanced Topics for Registry Professionals meeting.